The effect of the maternal plasma and breastmilk metabolome on the infant gut microbiome and growth

PROJECT SUMMARY
More than one million HIV exposed uninfected (HEU) children are born annually, with the majority in sub-Saharan
Africa. HEU infants are at an increased risk of poor linear growth, infectious morbidity, and mortality compared
to their HIV unexposed uninfected peers. Breastfeeding reduces but does not eliminate poor health outcomes in
HEU infants, despite improving maternal health with antiretroviral treatment. The biological mechanisms for
vulnerabilities in breastfed HEU infants remain unclear. There are significant gaps in our understanding of how
HIV infection affects breastmilk composition and the role of breastmilk composition in the development of poor
growth among HEU infants. It is biologically plausible that systemic metabolic dysfunction associated with
maternal HIV infection may alter metabolite levels in breastmilk and thereby affect infant outcomes. We
hypothesize that HIV will alter the maternal plasma and breastmilk metabolome and that these alterations will
be associated with the infant gut microbiome and infant growth.
We propose to leverage the Tunza Mwana Kenyan birth cohort (NICHD 5R01HD096999) including lactating
women living with and without HIV and their infants. Utilizing existing maternal plasma and breastmilk samples
from 60 cohort participants (30 with HIV and 30 without HIV) and prospective infant growth monitoring, we will
expand this unique cohort performing targeted metabolomics and machine learning to characterize metabolic
relationships between the mother-breastmilk-infant triad and to identify metabolomic profiles in plasma and
breastmilk associated with the infant gut microbiome composition and growth.
Specific Aims are to 1) determine how maternal plasma metabolites correlate with breastmilk metabolites, and
how plasma and breastmilk metabolites are associated with HIV in early (3 weeks) and later (6 months) lactation,
2) evaluate how breastmilk metabolites influence infant gut microbiome composition and diversity at 3 weeks
and 6 months, 3) identify maternal plasma and breastmilk metabolites and infant gut microbiome compositions
associated with growth to 24 months of life.
Career and Learning Objectives are to 1) acquire foundational and advanced skills in epidemiology and
biostatistics, 2) develop core competency in the conduct and interpretation of multi-omics studies, and 3)
strengthen skills in longitudinal cohort studies and clinical-translational trials. By accomplishing these learning
objectives and through the achievement of the specific aims in the research plan, the applicant will be well-
positioned to attain competitive external funding to implement future studies assessing the maternal-
breastmilk-infant triad and nutrition and growth outcomes.
Study Impact: This work will identify key elements in breastmilk that are disrupted and lead to profound effects
on infant health. New data generated on maternal metabolomic and infant gut microbiome profiles associated
with infant growth will inform potential targets for intervention.

Public health relevance
PROJECT NARRATIVE Despite breastfeeding and maternal anti-retroviral therapy, HIV-exposed uninfected infants have substantially higher risk of growth faltering and morbidity than HIV-unexposed uninfected infants. The proposed project will leverage a unique funded Kenyan birth cohort (NICHD 5R01HD096999) including lactating women living with and without HIV and their infants and expand this cohort to include targeted metabolomics of the maternal plasma and breastmilk to characterize the complex relationship between the mother-breastmilk-infant triad and identify metabolomic profiles associated with the infant gut microbiome and infant growth. Findings from this study will be used to develop targeted metabolomic and microbiome interventions for vulnerable HIV-exposed uninfected infants.